Randomized Trial of Stepped Palliative Care versus Early Integrated Palliative Care in Patients with Advanced Lung Cancer

Project Summary
Background: Early integrated palliative care (PC), entailing monthly visits with a PC clinician in the outpatient
setting throughout the course of illness for patients with advanced care, improves both patient-reported and
end-of-life (EOL) care outcomes. However, few institutions possess a sufficient number of PC trained clinicians
and resources to provide monthly visits with a PC clinician for all patients with advanced cancer. Additionally,
such frequent visits with a PC clinician may not be necessary for patients with minimal physical or
psychological symptoms. Stepped care is a health service delivery model to increase access to and efficiency
of care when there is a limited number of specialty trained clinicians. In stepped care, all patients receive care
with the minimal necessary time with the trained clinician, but are monitored systematically to “step up” to more
intensive treatment if they do not achieve sufficient health gain with low intensity treatment. Based upon our
multidisciplinary teams' extensive experience developing and studying early integrated PC in oncology, we
propose to adapt our effective outpatient PC model to a stepped care strategy to ensure all patients access PC
service, while tailoring treatment delivery to patients' needs. Study Aims: The specific aims of this multi-center
randomized trial are to demonstrate the non-inferiority of stepped PC to standard-of-care early integrated PC
with respect to its effects on quality of life (primary outcome), as well as patient-clinician communication about
EOL care preferences and length of stay in hospice. We will also compare PC resource utilization and the cost
effectiveness of the two delivery models. Study Design and Methods: We will enroll and randomly assign
480 patients newly diagnosed with advanced lung cancer (240 per study group) to receive either stepped PC
or early integrated PC. The trial will take place at Massachusetts General Hospital, Columbia University, and
Duke University. Patients randomized to stepped PC will meet with the PC clinician at enrollment and at
clinically relevant points in their illness. We will assess participants' quality of life every six weeks to detect
stepped care patients whose quality of life is deteriorating to allow them to step up to monthly PC visits.
Patients randomized to early integrated PC will participate in monthly visits with the PC clinician throughout
their course of illness. In addition to quality of life, all participants will complete measures to assess their health
status, mood, coping, prognostic understanding, and communication about their EOL care preferences every
12 weeks for one year. We will also collect data from the medical record and hospital cost accounting system
on hospice use, PC resource utilization, and health care costs. Conclusions: Early integrated PC improves
patient-reported outcomes, including quality of life and mood, and the delivery of EOL care. Based upon data
demonstrating the efficacy of this care model, several national organizations recommend early integrated PC
as standard of care. We seek to establish the non-inferiority of a stepped PC model compared with early
integrated PC, as a more efficient, accessible, patient-centered, and scalable approach to provide early PC.

Public health relevance
Project Narrative Early and longitudinal involvement of palliative care in the outpatient management of patients with advanced cancer improves patient-reported and end of life care outcomes. While recommended by national organizations as the standard of care, this early integrated care model utilizes substantial palliative care resources, which has limited its dissemination across care settings. We seek to demonstrate the non-inferiority of a less resource intensive stepped palliative care model in both improving quality of life and the delivery of end of life care compared with early integrated palliative care, as a means to deliver more efficient, accessible, and patient-centered care.